Administrative Supplement for Combining Experiments and Computer Simulation to Improve the Stem Cell Differentiation Process

ABSTRACT
The overall goal of this work is to experimentally observe stem cell differentiation, adipogenesis, of single cells to
gain a more accurate model of the changes in mechanobiology over time. The high-speed simulation model of
adipogenesis is currently based on observations of averaged ensemble properties of stem cell cultures. Because
the model is of a single cell, its accuracy and predictive capability can be improved by obtaining more data on the
changes in stem cell properties for single cells that can be tracked over time. An incubator will be developed as
part of this grant to sustain stem cells under a microscope for at least 15 days, which will allow photographs at
regular intervals of the morphology of the cell and nuclear membranes. However, time-dependent data on many
cell properties is still difﬁcult to obtain because the process of dyeing the cell to examine the state of its compo-
nents, or probing its properties with an optical tweezer, typically kills the cell. Thus, the cells will be sacriﬁced
after 15 days, and the high-speed simulation will be used work backward to estimate the initial properties related
to successful and unsuccessful adipogenesis. Comparing successful and unsuccessful differentiation will yield
biomarkers that provide early indication of successful adipogenesis, as proposed in Aim 1 of the parent grant.
These additional single stem cell experiments will complement the data obtained from the ensemble experiments
proposed in the parent grant.

Public health relevance
NARRATIVE This project combines modeling and experimental approaches to develop a high-speed computer simulation of long term cell mechanobiology. A key element of the work is a more extensive characterization of the mechanics of the cell and its contents, which will allow us to tune our high-speed computer simulation to more accurately predict the outcome of stem cell differentiation. This will further the development of incubator technologies for characterizing mechanobiological properties of single cells, which can be used to facilitate the study of many different cellular functions that are governed by mechanobiological processes.